LONG TERM OUTCOME BOSTON BRACE TREATMENT OF IDIOPATHIC SCOLIOSIS

To assess via bone densitometry study whether there is a significant difference in bone density between those adult subjects who wore the Boston brace for treatment for scoliosis as children versus those who did not.